Evaluating the utility of fNIRS in detecting and diagnosing AD/ADRD

Project Abstract
The US Census Bureau projects that people over the age of 65 years will number 77 million by 2034,
indicating a rapidly aging population. The World Health Organization projects a steady increase in the number
of individuals with dementia, with 82 million individuals by 2030. Further, according to the Alzheimer’s
Association, an estimated 6.5 million people are living with Alzheimer’ dementia, and the percentage of dementia
increases with age, 5.0% of people age 65 to 74, 13.1% of people age 75 to 84, and 33.2% of people age 85
and older have Alzheimer’s dementia 1. While there are a cluster of neurodegenerative disorders that constitute
dementia 2, mild cognitive impairment (MCI)3, fronto-temporal dementia spectrum disorders 4, 5 that includes
primary progressive aphasia 6, 7 and posterior cortical atrophy 8 are all characterized by language, cognitive and
memory deficits. All these individuals experience changes or subtle decline in their everyday abilities that are
hard to detect, however, once diagnosis is made these symptoms have deteriorated significantly. It is therefore
important to rigorously evaluate approaches that can detect and diagnose degenerative disorders early and
during daily activities where instances of abnormalities and changes first arise.
To be able to detect and diagnose degenerative disorders, we need to be able to continuously track
human brain function and behavior in the Everyday World. In the parent grant, we are developing the
“Neuroscience in the Everyday World” hardware, an fNIRS/EEG system with an integrated computer vision and
eye tracking device to measure brain and behavioral function in healthy adults, individuals with stroke or
Parkinson’s Disease as they go about their everyday lives. In this supplement, we aim to evaluate the utility of
fNIRS as a tool to examine the neurophysiological mechanisms underlying early language and cognitive changes
in individuals with AD/ADRD. In Aim 1, we will extend our wearable fNIRS system used to measure everyday
interaction, attention, working memory and walking in healthy adults, post-stroke individuals with aphasia to
adults with AD/ADRD and MCI. Building on our previous work, we will evaluate cortical activity during
conversation, walking and perceptual tasks in adults with AD/ADRD and MCI. We expect to detect differences
in the fNIRS signal between ADRD and healthy age-matched controls (collected as part of the parent grant) as
they perform these behavioral tasks. In Aim 2, we evaluate the relationship between behavioral (e.g., language
and cognitive) function and neural signatures in the fNIRS profiles in adults with AD/ADRD relative to healthy
controls. We will compare behavioral performance on the task measures with the magnitude of the fNIRS signal,
hypothesizing that individuals with AD/ADRD with higher behavioral performance will show greater fNIRS signal
magnitude relative to the ones with poorer behavioral performance. The proposed work has a high impact as it
allows the examination of neural and behavioral markers of early neurological dysfunction during everyday
activities such as interaction or dual task walking (multi-tasking while walking) leading to future research on
understanding the mechanisms of early neurological changes in AD/ADRD.

Public health relevance
Project Narrative In this supplement, we will examine neural and behavioral markers of early neurological dysfunction in AD/ADRD during everyday activities such as interaction, dual task walking and attention/working memory using our newly developed fNIRS system in the parent grant. This supplement will provide important preliminary and feasibility data on our fNIRS tasks on adults with AD/ADRD, which will then lead to future R01 grants that can examine the utility of fNIRS as a cognitive screening tool.